Hydroxychloroquine for the Management of CVD in CKD

Cardiovascular disease (CVD) is the most prominent cause of morbidity and mortality among patients with
chronic kidney disease (CKD), and end stage kidney disease (ESKD). Unfortunately at the present time, we do
not have an effective treatment to reduce the high CVD mortality in these populations. Accelerated
atherosclerosis, inflammation, and vascular stiffness are prominent factors contributing to CVD in CKD.
Interventions that can effectively counter these factors may provide significant benefits for the management of
CVD in CKD. Hydroxychloroquine (HCQ) is an inexpensive and safe anti-inflammatory drug that has been in
clinical use for over 4 decades even in patients with CKD and ESKD. In recent times, multiple in vitro, in vivo,
and human cohort based data have shown that HCQ benefits multiple parameters of CVD, including
inflammation, endothelial function, metabolic syndrome, insulin sensitivity and atherosclerosis. Recently we
through our animal validated that HCQ indeed has significant anti-atherosclerosis and vasculoprotective effects
in CKD milieu. We further conducted a small, human, feasibility study that shows a potential for HCQ on
parameters relevant to CVD in CKD.
The next step requires evaluation of HCQ's role for the treatment of CVD in CKD. However, in the absence
of a universally agreed-on surrogate for CVD, a proof-of-concept clinical study needed to validate the anti-
atherosclerosis and vasculoprotective potential of HCQ in CKD. We propose such a study that will enroll 90
albuminuric, stage 3b CKD subjects in a randomized controlled trial (RCT) with 1:1 allocation (HCQ : placebo),
stratified by their diabetes status, and treat for a duration of 18 months. We will examine the effects of HCQ on
structural, functional, and biochemical measures of atherosclerosis and CVD.
Specific Aim (SA) 1 will evaluate the ability of HCQ, compared to placebo, to slow the progression, or reverse
atherosclerosis. We will evaluate the progression of carotid atherosclerosis with a non-contrast MRI performed
at baseline and after 9 and 18 months of treatment with HCQ or placebo. The primary outcome measure will
be change in total carotid plaque volume (TPV). Secondary outcome measures will be changes over time in
total plaque surface area, maximal stenosis, and the type (fibrous, stable, or unstable), and stability of plaques.
Specific Aim 2: will evaluate the extent to which HCQ can affect inflammation (SA2a), and vascular stiffness
(SA2b) in CKD. We will examine the effects of HCQ and placebo at baseline, and at 6, 9, 12, and 18 months
on the secondary outcome measures of high-sensitivity C-reactive protein (SA2a) and aortic pulse wave
velocity (SA2b).
Though the sample size and power calculations have been designed for the primary outcome (SA1), we
will have adequate power to evaluate meaningful impacts of HCQ on the secondary outcomes in SA2.
Specific Aim 3 will examine the effect of HCQ and placebo on the trends of hard cardiac and renal outcomes
and drug safety. While not powered to detect the differences in the rates of these clinical events, trends in
outcomes, drug safety, and tolerability are mandatory and will assist in the planning of the future, definitive
RCT.
If the results of this trial are positive with a favorable AE profile, it will provide critical preliminary data to
justify and plan a definitive, multicenter RCT to examine the effects of HCQ on hard outcomes of CVD in CKD.
Additionally, this study may provide insights into the importance of select inflammatory and vascular factors in
CVD with wider future implications for those with CKD and perhaps the general population.

Public health relevance
Chronic kidney disease (CKD) is the 4th most common diagnosis amongst US veterans costing VHS, $18 billion annually. Cardiovascular disease (CVD) is the single largest killer for these patients. At present time we do not have an effective strategy capable of reducing the exceedingly high CVD mortality in those with CKD. We propose a novel therapy for this deadly disease and plan to conduct the first human proof-of-efficacy study to examine whether it can impact the parameters of CVD in Veterans with CKD. Based on multiple in vivo, in vitro, and population-based data, as well as our recently concluded validatory animal and human feasibility studies, we believe that [hydroxychloroquine (HCQ)], a traditional, safe, and cheap anti-inflammatory drug will have significant benefits relevant to CVD in CKD. The outcome of this study has the potential to provide an entirely new line of therapy for the treatment of CVD, not only in CKD, but in general population as well, and in the process, may establish a new field of research to attack CVD.